Big data analytics for the evaluation of whole genome sequence and transcriptome data in alcohol research

PROJECT SUMMARY/ABSTRACT Large-scale U.S. epidemiological studies demonstrate that alcohol use disorders are highly prevalent, highly co-morbid with other psychiatric disorders, disabling, and often go untreated. Compared with other U.S. ethnic groups, Native Americans have the highest rates of alcohol and other drug dependence, and it is associated with particularly significant disability and mortality. Thus studies that identify specific genetic risk factors for alcohol use disorders in the general U.S. population, and especially in Native Americans, are of high public health importance. Alcohol use disorders are complex genetic diseases sensitive to environmental conditions that require complex data strategies to uncover the underlying risk factors. Although recent years have seen significant advancement in our understanding in the biology and genetics of the disorders, exactly how these factors interact in an individual to confer risk or protection from alcohol use disorders is still unclear. Further, the genetic factors identified in the human genome thus far by conventional methods appear to only explain a very small fraction of the overall heritability for the disorders. The overall objective of this research program is to identify the complex genetic and genomic factors that affect susceptibility to alcohol use disorders and related comorbidities through novel and innovative quantitative methods and big data analytics. The proposed study will utilize whole-genome sequence (WGS) data from a unique high-risk Native American population and a European American population along with gene expression data of alcoholic human brains. The project will develop methodology to analyze WGS data with unique relevance to alcohol research. Selected multivariate, graphical, and dimension-reduction modeling tools will be used in combination with mixed models suitable for genomic data with both population and family structures to dissect polygenic basis for alcohol use disorders and shared genetic risk factors for alcohol use disorders and comorbid disorders. Mixture models and clustering methods will be employed to uncover heterogeneous genetic influences. Differential genetic effects at various levels of heterogeneity will be tested with rigorous statistical methods. The project will identify population and ancestry-specific genetic risk factors and shared risk factors across populations and determine their differential influences on susceptibility to alcohol use disorders. Endophenotypes will also be investigated to help identify unique risk factors for alcohol use disorder traits. The project will further identify alcohol- and addiction-relevant pathways and networks that are differentially expressed in alcoholic brains, and establish directions of causations by combining gene expression data with WGS data, and applying instrumental variable approaches. Finally, an integrated system approach will be taken by further leveraging epigenomic maps and annotation databases in the public domain to build predictive and potentially causal models aimed at more “personalized” prevention and intervention for alcohol use disorders in specific high-risk groups and individuals.

Public health relevance
PROJECT NARRATIVE Alcohol use disorders are prevalent, frequently co-occur with other psychiatric disorders, are disabling and often go untreated. Identifying specific genetic risk factors for alcohol use disorders in the general U.S. population, and especially in high risk ethnic groups such as Native Americans, will lead to more personalized thus more effective prevention and intervention for alcoholism in these populations.